A Randomized Phase 2A Clinical Trial Pioneering the Utility of an eNAMPT-Reducing Therapy in ARDS/VILI: the PUERTA Trial

ABSTRACT
The serious unmet need to address the excessive mortality observed in patients with Acute Respiratory Distress
Syndrome (ARDS) has been brought sharply into focus by the current COVID-19 pandemic. In this R-44
application, Aqualung Therapeutics will address this therapeutic gap by utilizing a novel, humanized monoclonal
antibody, ALT-100 mAb, which binds/neutralizes a novel ARDS target, eNAMPT (extracellular nicotinamide
phosphoribosyltransferase), to reduce ARDS/VILI severity. We have shown that eNAMPT functions as a DAMP
(tissue damage-associated molecular pattern) that binds Toll-like receptor 4 (TLR4) to elicit profound NFkB-
driven inflammation, processes we have shown to be involved in pathobiology of ARDS and mechanical
ventilator-induced lung injury (VILI). Importantly, we demonstrated that eNAMPT is a highly druggable
ARDS target with the ALT-100 mAb profoundly attenuating the cytokine storm and inflammatory lung injury in
preclinical models of ARDS/VILI including a porcine model of septic shock-induced ARDS/VILI. We completed
GLP IND-enabling pharmacokinetic (PK) studies (T1/2 half-life of 12-14 days) and toxicity studies (rats/pigs)
which failed to identify any discernable level of toxicity even up to 50 mg/kg of ALT-100 mAb (28 day study).
Importantly, we have completed CMC and a 200L cGMP Bioreactor run (expression 6 gms/L) generating
sufficient mAb for completion of a first-in-human (FIH) Phase 1A safety ascending dose study clinical trial in
healthy volunteers (beginning June 2022) and the Phase 2 A safety/efficacy study called PUERTA (Pioneering
the Utility of eNAMPT-Reducing Therapies in ARDS/VILI) in ARDS subjects with sepsis, septic shock, trauma,
bacterial or viral pneumonia, or COVID-19 infection. We anticipate FDA Investigational New Drug approval in
Q2 2022 for the ALT-100 mAb as an ARDS therapeutic intervention. This R-44 award will support the PUERTA
P2A trial of ALT-100 mAb in 90 severely hypoxemic subjects (2:1, ALT-100:placebo) with the diagnosis of
moderate-to-severe ARDS (P/F <200) who are immediately treated with mechanical ventilation (MV), with high
flow nasal O2 (HFNO) or non-invasive ventilation (NIV i.e. BIPAP/CPAP). SA #1 will assess safety, tolerability,
and PK of ALT-100 mAb at 2 dose levels (1mg/kg or 4 mg/kg) compared to placebo. SA #2 will assess the
capacity for ALT-100 mAb to reduce ventilator requirements (# ventilator-free days), the incidence of multi-organ
failure (MOF), the need for MV in HFNO/NIV-treated ARDS subjects, and reductions in plasma cytokines i.e.
pharmacodynamic effects [PD] SA #3 will assess predictive capacity of plasma eNAMPT levels and NAMPT
SNPs in identifying PUERTA subjects who respond to single dose treatment with ALT-100. The R-44 PUERTA
trial, overseen by our CRO, Prevail Infoworks and conducted at 5 academic clinical sites, will directly address
the unmet need for novel ARDS therapies and confirm eNAMPT as a highly druggable therapeutic target for
ARDS. Successful achievement of R-44 milestones will lead to further investigation of ALT-100 mAb in larger
pivotal P2b/P3 studies to determine efficacy of treatment with ALT-100 mAb to reduce ARDS/VILI mortality.

Public health relevance
NARRATIVE The COVID-19 pandemic, with associated unprecedented ARDS/VILI mortality rates, dramatically highlights the absence of FDA-approved ARDS/VILI pharmacotherapies. Aqualung Therapeutics has identified a novel ARDS/VILI target, eNAMPT, and have developed a highly effective monoclonal antibody, ALT-100 mAb, to directly addresses the serious unmet therapeutic need for novel ARDS/VILI therapies. Both ALT-100 mAb safety and efficacy will be assessed in the proposed R-44 PUERTA trial, a randomized Phase IIA clinical trial, as well as the development of an individualized therapeutic approach to reduce ARDS mortality.